Identification of Sub-phenotypes in Sepsis Associated Acute Kidney Injury

PROJECT SUMMARY/ABSTRACT Acute kidney injury (AKI) occurs in over 50% of patients with sepsis and is associated with increased risk of mortality and other complications, including longer hospital length of stay and the development or progression of chronic kidney disease. To date, therapies for sepsis associated AKI (SA-AKI) remain largely supportive. One possible reason for the failure of targeted therapies may be the currently limited understanding of the pathophysiology of the condition. Traditionally, SA-AKI has been thought to be largely due to renal ischemia secondary to hypoperfusion. However, animal models show that SA-AKI is actually a state characterized by hyperdynamic circulation, and review of histological changes in septic patients shows a lack of acute tubular necrosis, a pathological finding often associated with renal ischemia. Rather, it appears that a combination of immunologic, toxic and inflammatory factors likely leads to SA-AKI, and intervening along these pathways may improve patient outcomes for SA-AKI. We hypothesize that within a population with SA-AKI, there are subgroups who have particular inflammatory and immunological profiles that are associated with differential outcomes and response to therapies. In the fields of asthma and the acute respiratory distress syndrome, the use of clinical data and biomarkers to identify such subpopulations, or sub-phenotypes, of disease, has led to new treatment paradigms, where individuals with a specific biological profile receive and benefit from a targeted therapy. We propose to use data from a large, established cohort of patients admitted to the Intensive Care Unit (the Early Assessment of Renal and Lung Injury [EARLI] cohort) to define sub-phenotypes of SA-AKI using latent class analysis. Latent class analysis is an established method that uses mixture models to identify sub- phenotypes within a heterogenous population in an unbiased manner. Prior work using this methodology has allowed for discovery of new disease entities that inform biological pathways of cellular injury leading to organ failure. Our specific aims are: Aim 1: To identify novel sub-phenotypes of patients with SA-AKI and discover molecular targets for therapy through the incorporation of clinical and biomarker data into our latent class analysis. Aim 2: To determine whether certain sub-phenotypes are associated with differential outcomes with regards to mortality, need for renal replacement therapy, or duration of AKI. Through the studies outlined in this F32 proposal, Dr. Kwong will learn how to rigorously conduct latent class analysis as well as other unbiased analytic techniques (e.g., machine learning) and to apply these techniques to AKI. This work will effectively position Dr. Kwong for her future research studies, where she wants to identify appropriate patients for clinical trials of AKI therapies and to better define the pathophysiology of human AKI.

Public health relevance
PROJECT NARRATIVE Sepsis has been shown to be a key contributing factor for the development of acute kidney injury (AKI). To date, there are no available targeted therapies for sepsis-associated AKI besides supportive care with antibiotics and fluids. The long-term goal of this project is to find new therapeutics for sepsis-associated AKI by first identifying sub-phenotypes based on clinical and biomarker profiles that may inform the molecular pathways of injury and then determining their association with adverse outcomes.